A Platform to Identify Antifungal Compounds with Novel Action Mechanisms

Project Summary
There is societal need for new compounds in our arsenal of defenses against fungal
pathogens, many of which are increasingly resistant to existing therapeutics. Antifungal
compound discovery has been forgotten or neglected (see a review publication 2021 at
Research Strategy). One of the best possible sources for new antifungal compounds
with potentially novel mechanisms of action is within filamentous fungi, which have the
greatest diversity of microbial life. This research proposal advances the science of
metagenomics, to demonstrate Aspergillus nidulans as both a heterologous host and an
initial antifungal screening target, to integrate with RNA sequencing and fungal pathogen
screening of fungal biosynthetic gene clusters (BGCs) and genomes, and to discover
novel antifungal chemicals and identify the best lead candidates for clinical
development. Scientists at Intact Genomics, and University of Wisconsin at Madison
have combined four key technological breakthroughs that result in an improved
paradigm for screening small molecules. The improvements in fungal artificial
chromosome (FAC) tools include: 1) an improved methodology for heterologous
expression of full-length BGC-FACs; 2) the FAC heterologous strains expressing
antifungal compounds also showing abnormal phenotypes; 3) new action mechanisms
of abnormal phenotype BGC-FACs to be uncovered by RNA deep sequencing; 4) a
panel of fungal pathogens for rapid and improved screening method to identify novel
antifungal compounds. This Phase I SBIR will build upon the success of previous
research by screening FACs for antifungal compounds. We will characterize the
antifungal agents expressed by BGC-FAC clones and FAC libraries to determine the
best lead candidates for clinical development. Lead candidates will have novel chemical
structures, have high potency against multiple fungal pathogens, and minimal toxicity
against human red blood cell. Each of the different technologies necessary for the
proposed research has been proven effective separately; therefore, the synthesis of
these different methods has a high probability of success and also represents a
significant advancement for the science of antifungal discovery.

Public health relevance
PROJECT NARRATIVE In the fight against fungal infectious diseases, we are losing ground due to the development of antifungal resistance and our inability to find replacement drugs with novel action mechanisms. The loss of life and the burden of treatment is a significant public health threat to American citizens. The proposed research unleashes a new set of tools for drug discovery that permits access to the diverse fungi for novel antifungal compounds to combat the threat of fungal pathogens.